Molecular Imaging: Training for Oncology

DESCRIPTION (provided by applicant): The goal of this program is to train a new generation of researchers, to become facile with both the biology and the technology of "molecular imaging". The term "molecular imaging" has been applied to imaging techniques that combine benefits from 2 complementary scientific developments, namely, 1) the improving technology of imaging leading to ever more versatile and high resolution imaging modalities for both laboratory and clinical applications; 2) advances in understanding of cancer biology which are exploited to create imaging probes for the key molecules and related biochemical events that are fundamental to neoplasia. As knowledge increases, interdisciplinary training will be needed, if these advances are going to be quickly translated into cancer discovery. At Memorial Sloan-Kettering Cancer Center (MSKCC), there has been rapid growth in molecular imaging capabilities and resources fueled by NCI funded initiatives including the P50 In Vivo Cellular and Molecular Imaging Center (ICMIC), the small animal imaging resource program (SAIRP), and multiple oncology directed PO1 's, SPORES, and RO1's that stress the multimodality biologic imaging of cancer. This "team science" experience suggests that training is required from 2 distinct points of perspectives: clinical researchers need more molecular biology and training in laboratory imaging methods; basic researchers need training in specialized imaging methods, and a more focused and relevant clinical oncology perspective. This R25T program is designed to meet these diverse training needs. The program will be managed through an internal advisory committee consisting of clinical and basic faculty with experience in graduate medical education in oncology. Mentors will be drawn from a distinguished group of NCI supported cancer researchers. Both basic and clinical trainees will be recruited, with emphasis on equal opportunities for minorities. A specialized curriculum will include the relevant molecular biology, research methodology, instruction in advanced imaging methods, and an individualized research program of basic, translational and clinical.